CROSS CALIBRATION OF SUBJECTS BETWEEN QDR 2000 PLUS AND THE QDR 4500

The purpose of this study is to perform crossover studies between the old and the new densitometers in the Integrative Physiology Core Laboratory. This study was done so that bone mineral density data could be compared between different generation of machines in different physical locations. Specifically, we wanted to compare results we have gathered for years on the mainly Caucasian population at our downtown location with the new minority populations which have been studied at the GCRC. No further studies of this nature are planned.